Development of a Personalized Intervention to Motivate Health Behavior Change in Midlife Adults at Risk for Alzheimer's Disease

PROJECT ABSTRACT
Modifiable risk factors such as physical activity, healthy diet, stress reduction, and cognitive stimulation are
associated with lower risk of Alzheimer’s disease (AD) and related dementias. Population-level engagement in
positive health behaviors in midlife and early late life is low, and large, multi-domain prevention trials have
reported a positive impact of lifestyle modification on risk for cognitive decline. However, adherence to trial
protocols is poor despite intensive individualized coaching, raising concern about generalizability and the ability
to motivate sustained behavior change. The objective of the funded parent award is to use the science of
behavior change to develop a theoretically grounded, personalized health education intervention that will
motivate sustained health behavior change to prevent or delay the onset of Alzheimer’s disease (AD). The goal
of this administrative supplement is to prepare Ms. Idania Arias, BA, for the next stage of her career by
providing mentored training in qualitative methods and intervention development. Ms. Arias is an exceptional
post-baccalaureate candidate from a background under-represented in the health sciences. Ms. Arias will
complete a research project that builds upon the parent project by understanding the relationship between
individual health beliefs and structural barriers to health behavior change. Under mentorship of study MPIs,
she will use qualitative methods to assess the degree to which participants interested in a health behavior
change program endorse structural barriers to behavior change (Aim 1) and characterize the interaction
between individual health beliefs and structural barriers (Aim 2). Results will inform development of an
enhanced healthy living education intervention. This proposal also includes a detailed training plan that will
help Ms. Arias 1) develop expertise in qualitative methods; 2) gain experience in community-based
participatory research to promote recruitment of diverse populations; and 3) engage in professional
development opportunities to prepare her for graduate training in clinical neuropsychology.

Public health relevance
PROJECT NARRATIVE Modifying health behaviors like physical activity level, diet, stress, and mental activity level can lower risk for Alzheimer’s disease, but many middle-aged and older adults find it difficult to sustain health behavior changes over the long term. This project will examine the relationship between individuals’ beliefs about their health and structural factors such as social determinants of health (e.g., finances, access to resources, racism). This will help us develop an intervention to help people sustain health behavior changes to prevent or delay the onset of Alzheimer’s disease and related dementias.